The effectiveness of screening women with lower genital tract neoplasia or cancers for anal cancer precursors

PROJECT SUMMARY/ABSTRACT
We recently reported that SCCA incidence (particularly advanced-stage disease) and mortality rates are
increasing rapidly (>3% per year) in the US with notable (>5%/year) increases in women 50 years and older
showing that SCCA is one of the fastest accelerating causes of cancer incidence and mortality among all
cancer sites. Women with lower genital tract (cervical/vaginal/vulvar) dysplasia or cancer (WLGTN) represent a
large population (>200,000 new cases per year) at elevated risk of developing SCCA. We and others have
shown that the incidence of SCCA among WLGTN aged 50 years and older is over 20 per 100,000 persons,
which is both comparable to the incidence rate among women with HIV (who are the focus of current screening
efforts) and is similar to the cervical cancer incidence prior to widespread screening. Furthermore, HPV
vaccination is unlikely to decrease SCCA incidence in this population both because WLGTN have already
been exposed to oncogenic HPV, and vaccine rates remain low among US women. This highlights an urgent
need for studies evaluating possible targeted prevention in the form of anal cancer screening. Our goal is to
evaluate the benefits and harms of SCCA screening among WLGTN. Screening for SCCA involves the
identification of precancerous anal lesions (high-grade squamous intraepithelial lesions or "aHSILs") using
cytologic testing or HPV testing (potentially performed by patients themselves). These lesions (if histologically
confirmed) can then be treated, thereby preventing carcinoma development, similar to practices widely
endorsed for cervical cancer. To inform guidelines, data regarding screening characteristics, natural history,
patient acceptability, the benefits and harms, and cost-effectiveness of screening for SCCA among WLGTN,
are urgently needed. We therefore propose a two-site, two-year longitudinal study of 350 HIV uninfected
WGLTN aged ≥45 years. The results of this longitudinal study will be used to synthesize a mathematical
(simulation) model that will estimate clinical and population-level benefits versus harms and cost-effectiveness
associated with different screening approaches. The Specific Aims are: (1A) To evaluate the respective
screening test characteristics of anal cytology, clinician-collected and self-collected high-risk HPV (hrHPV)
testing, and cytology/hrHPV cotesting compared to the gold standard of high-resolution anoscopy (HRA) exam
with biopsy; (1B): To determine baseline anal hrHPV and histologic aHSIL (haHSIL) prevalence and
longitudinal risk among WLGTN; (2): To compare patient acceptability and experiences for anal cancer
screening strategies among WLGTN; and (3): To develop a mathematical model determining the potential
mortality and morbidity benefits, harms, and cost-effectiveness of anal dysplasia screening and/or hrHPV
testing in WLGTN. In summary, the proposed multidisciplinary study will generate much-needed data regarding
the optimal SCCA screening approach for WLGTN, necessary to inform national screening recommendations
for WLGTN. This study will have direct implications for clinical cancer prevention practices.

Public health relevance
PROJECT NARRATIVE Anal cancer incidence is rapidly rising in women and preventive measures such as screening have received little study in this group. Therefore, we will conduct a prospective, longitudinal study evaluating screening modalities for anal cancer precursors women with a history of lower genital tract neoplasia or cancer to determine the performance and acceptability of different screening tests and strategies as well as define the natural history of disease. These data will be used to inform a decision analysis to assess the overall benefits, harms and costs of screening.